STSS - TASK ORDER 15 - PROGRAM SUPPORT SERVICES 3.0

Shared collaborative cloud environment, including cloud-based productivity tools, a service desk, commercial and open-source deployments of analytical tools for NCATS Extramural Programs.